VIOLENT BEHAVIOR, NEUROTRANSMITTERS, GLUCOSE METABOLISM, AND ALCOHOL ABUSE

We have investigated neurotransmitter metabolites and glucose metabolism in incarcerated violent offenders, arsonists and healthy volunteers. We have found that low cerebrospinal fluid 5- hydroxyindoleacetic acid (5HIAA) concentrations and hypoglycemias during oral glucose tolerance tests are associated with each other and impulsive violent acts and fire setting.